Admin Core

Sylvester Comprehensive Cancer Center (Sylvester) Administration (SA) operationalizes Sylvester’s five-year Strategic Plan (SP) by developing and maintaining an efficient research infrastructure that fosters collaboration, communication, and cancer research excellence. The administrative support provided by a cohesive, highly trained administrative staff has contributed to a steady growth in the peer-reviewed funding, high-impact publications, faculty recruitments, collaborative research and overall capabilities of Sylvester, a recently NCI-designated cancer center. Dorothy Graves, PhD, Associate Director Administration and Sylvester Assistant Vice President, leads a dynamic and skilled administrative team that supports the Cancer Center Director, other Sylvester leadership, and a total of 148 Cancer Center members in their mission to reduce the human burden of cancer in Sylvester’s South Florida catchment area (CA). SA provides oversight and management of all research administrative areas and activities through the following specific aims to: 1) Manage and support all aspects of the CCSG, 2) Facilitate the development and execution of Sylvester’s five-year SPs, 3) Facilitate collaborative, transdisciplinary, and CA-relevant science across the Center, 4) Provide effective oversight and management of Sylvester financial resources, space, and facilities and 5) Advance Sylvester education and training, and community outreach and engagement activities, supporting the creation of a more effective workforce. During the reporting period (6/1/18–5/31/23), SA grew broadly, from 59 to 105 staff, to support the operational, non-clinical research needs of the growing and maturing cancer center and the needs of the growing community it serves. SA was able to expand its services and provide Sylvester members with an increasingly robust, cancer-focused infrastructure supporting 44 new member recruits and an operational budget that grew by 51% during the reporting period. Sylvester members have garnered $27.9M in peer-reviewed funding; that includes funding from 58 multi-PI grants (as of 5/31/23), and $12M in NCI research funds. Trainees and early career faculty received 33 training grants, and members published 1,872 peer-reviewed manuscripts, of which 30% were published in journals with an impact factor >10. Through the investment of $11.9M in CCSG and Sylvester Developmental Funds, $58.7M in extramural funding was obtained. SA effectively leverages University of Miami resources such as the Office of Research Administration, Institutional Review Board, Information Technology, and Community Engagement, Government Relations, Marketing and Communications, and Human Resources to ensure synergistic relationships, streamlined processes and coordinated administrative support, enabling Sylvester to accomplish CCSG-aligned growth and success.